Exploring the anti-inflammatory properties of cannabis and their relevance to insulin sensitivity

Project Summary
As U.S. states decriminalize and legalize cannabis, its use is on the rise. Given the popular conception and
some empirical evidence that cannabis users experience increased caloric intake during acute intoxication,
there are concerns that higher rates of recreational marijuana use could exacerbate the current public health
crisis of obesity and associated metabolic disease; chiefly type 2 diabetes. Paradoxically, however, cross
sectional data demonstrate associations between chronic marijuana use and lower body mass index (BMI),
prevalence of obesity, insulin resistance, and rates of type 2 diabetes, despite data supporting higher caloric
intake acutely. Preliminary data from our lab suggest that different cannabinoids present in marijuana strains
(e.g. Δ9-tetrahydrocannabinol (THC) and cannabidiol (CBD)) render differential biologic effects on processes
relevant to type 2 diabetes like insulin resistance via effects on inflammatory markers. Critically, there is huge
diversity in the amounts and ratio of THC and CBD commercially available and widely used in states like
Colorado and their impact on obesity processes is not known. Variations in the underlying inflammatory state
that may result from the potency or constituent components of cannabis as it is now used likely relate to
variability in insulin sensitivity, a critical biomarker of type 2 diabetes.
We propose to carefully study the effects of cannabinoids on inflammatory cytokines and insulin sensitivity
in cannabis users across the weight spectrum. Our global hypothesis is that the inflammatory effects of
cannabis use vary as a function of the ratio of CBD to THC, and that inflammation may be a pathway by
which cannabis influences insulin sensitivity and, thus, risk for type 2 diabetes. Data from this
rigorously designed study may shed light on the cannabis use/metabolic disease paradox. The goal is
to test the effects of three real world commercially-available cannabis strains that differ markedly in their ratio
of CBD to THC. To that end, we will test the effects of three different cannabis products: a CBD product
(14% CBD, 0% THC), a THC product (14% THC, 0% CBD), and a THC+CBD product (7% THC, 7% CBD) on
inflammation and insulin sensitivity both acutely and chronically. We employ two observational designs: a study
of acute effects with infrequent users who have been abstinent at least three months and a study of more
sustained effects in cannabis users assigned to four weeks of use of one of three cannabis flower strains
versus a matched control group who do not use cannabis. Blood levels of THC and CBD will be measured
before, during, and after the exposure period in both cases, and associations between THC and CBD in blood
and both inflammation and insulin sensitivity will be measured. Results from these studies will provide critical
and timely data to the public and health professionals regarding the effects of cannabis use, including
differential effects of various strains, on diabetogenic processes. These data are urgently needed in order to
inform individual and policy level decisions in order to reduce the harm of cannabis use.

Public health relevance
Project Narrative Given that cannabis use for recreational and medical purposes has more than doubled in the US in the past decade, research aimed at understanding cannabis's effects on public health is critically important. Cannabis use has mixed associations with several metabolic processes, including increased caloric intake and, paradoxically, lower risk of type 2 diabetes, which suggests that increases in cannabis use could have a complex relationship to skyrocketing rates of type 2 diabetes in the U.S. The goal of this study is to begin to understand this paradox by examining the impact of cannabis strains that differ in the amount of THC and CBD (the two major cannabinoids in cannabis) on diabetogenic biological processes, in order to inform drug discovery, individual choices regarding the use of cannabis, policy decisions regulating cannabis strains, and to ultimately help to reduce the potential harm of cannabis use with respect to type 2 diabetes.